ANTI-RETROVIRAL THERAPY OF HUMAN IMMUNODEFICIENCY VIRUS INFECTION

An intensive effort was directed toward studying the preventive and therapeutic aspects of human immunodeficiency virus (HIV) infection and the acquired immunodeficiency syndrome (AIDS). A randomized trial comparing therapy with zidovudine (ZDV) versus interferon-alpha (IFN- alpha) versus the combination in 180 patients with early HIV-1 infection completed accrual and is currently active. A dose-tolerance study of the combination of IFN-alpha and dideoxyinosine (ddI) completed accrual of 53 patients and is now gathering long-term follow-up data. A randomized, double-blinded, placebo-controlled Phase II study of L-697,661 versus ZDV completed accrual of 84 patients. In this study, plasma viremia was found to be a reliable surrogate for anti-viral activity and the early development of resistance was noted using surrogate markers as efficacy parameters. A randomized, dose escalation study of U-90152S in combination with ZDV and ddI versus ZDV and ddI alone has enrolled 18 patients and continues to enroll. A dose-escalation study of PMEA has enrolled 12 patients and continues to enroll at the second dose level. Early results suggest that this agent has anti-retroviral activity in vivo. A phase I study of CD4-Pseudomonas Exotoxin (sCD4-PE40) in HIV- infected patients was initiated and enrolled 24 patients to determine the pharmacokinetics, maximally tolerated dose, and preliminary efficacy of this agent. Follow-up analysis of a randomized, controlled, masked trial of foscarnet in the treatment of cytomegalovirus retinitis in AIDS patients demonstrated an apparent survival benefit of this therapy.